Head and Neck Training Program in Surgical Oncology

PROJECT SUMMARY/ABSTRACT
Originally awarded in 1992, this application requests a five-year renewal of the T32 Head and Neck Training
Program in Surgical Oncology at Memorial Sloan Kettering Cancer Center (MSK). The mission of the Head
and Neck T32 program is to train a highly selected group of talented head and neck oncologic surgeons to
become high-caliber translational scientists and future academic leaders who will be positioned to advance the
management of head and neck cancers. MSK, an NCI-designated comprehensive cancer center, provides a
fertile environment rich in scientific and clinical resources that support intensive training in translational
research. This T32's research training strategy integrates the following key components: (1) a committed and
experienced Program Faculty spanning a wide range of scientific disciplines, with established track records of
successful mentorship; (2) immersion into rigorous scientific research training in an R01-funded laboratory with
appropriate guidance; (3) didactic research coursework; and (4) career development workshops. Each year,
two new postdoctoral (MD or MD/PhD degrees) trainees are appointed to the Head and Neck T32 training
grant for two contiguous years of dedicated research training. During this period, Head and Neck T32 trainees
engage full-time in basic or translational mentored research related to head and neck cancers. Areas of
potential research include genomics, molecular biology, cell biology, signal transduction, immunology,
transgenic mouse modeling, chemoprevention, experimental therapeutics, and others. Research projects are
matched to the particular academic interests and goals of the T32 trainee. Head and NeckT32 trainees will
also enter a formal didactic program in head and neck oncology and research training, designed to supplement
their individualized mentored research training. Career development workshops and seminars will help to
prepare the T32 trainee for a successful competitive academic career. These workshops focus on grant writing
skills, applying for career development awards, and developing the tools necessary for future independent
research support. Head and Neck T32 trainees will be monitored closely and are expected to meet training
milestones at designated time points. Specific expectations are delineated for trainee publications, grant
submissions, national meeting presentations, and attendance at didactic conferences. Historically, a high
proportion of trainees supported by the MSK Head and Neck T32 training program have entered academic
head and neck surgical oncology and gone on to become prominent figures in the field, reflecting the
effectiveness of this continuing program.

Public health relevance
PROJECT NARRATIVE Incidence rates for thyroid cancer and human papilloma virus-related head and neck cancers are steadily rising, and tobacco-related head and neck cancers continue to be identified as a public health priority by the NIH. Research at the cellular, genetic, and molecular levels has revealed that cancers of the head and neck have a complex biology, distinct from other cancer types. The T32 Head and Neck Training Program in Surgical Oncology at Memorial Sloan Kettering Cancer Center trains qualified clinician-scientists in head and neck cancer basic and translational research to specifically address these unique diseases.